Alpha9*-Nicotinic Receptors in Autoimmunity and Inflammation

DESCRIPTION (provided by applicant): Inflammatory and autoimmune disorders are personally and financially costly and are not very responsive to current therapies. Toward a long-term goal of successfully treating these disorders, this project seeks to identify roles in them played by nicotinic acetylcholine receptors (nAChR), specifically, those containing α9 subunits (α9*-nAChR). Cholinergic signaling and interplay between the immune, autonomic and central nervous systems have been implicated in inflammatory and anti-inflammatory responses. We and others have shown that nicotine exposure protects against inflammation and immune attack in the experimental autoimmune encephalomyelitis (EAE) model of multiple sclerosis (MS). However, our understanding is deficient about what specific nAChR are involved in anti- or pro-inflammatory responses, in immunity/ autoimmunity, and in immunosuppressive effects of nicotine, and about the cellular origins of these nAChR. Our preliminary findings suggest that α9*-nAChR are richly expressed in the immune system, because nAChR α9 subunit message levels are higher there than in the nervous system, perhaps except for the cochlea. Moreover, whereas nicotine protects against induction of EAE in wild-type mice, it seems to have no effect in mice lacking nAChR α9 subunit expression. However, the temporal pattern for development of EAE and its severity in α9-/- mice are like those in nicotine-treated, wild-type animals. That is, genetic deletion of α9*-nAChR or their pharmacological block (nicotine is an antagonist of α9*-nAChR function, in contrast to its effects as an agonist at other nAChR subtypes) seem to be equally protective against EAE. This exploratory/developmental project will test the overarching hypothesis that immune cell α9*-nAChR play pro-inflammatory roles and are engaged in autoimmune responses. One aim is to define nAChR α9 subunit expression profiles, under control conditions and in the course of inflammatory responses, in purified and/or sorted populations of peripheral or central immune cells. Another aim is to employ constitutive and conditional nAChR α9 subunit knock-out mice to define roles for α9*-nAChR in immune and inflammatory responses in the EAE model and in nicotine sensitivity of those responses. We expect to obtain essential information about the immune system distribution of α9*-nAChR and to elucidate roles that they play in inflammation and autoimmune responsiveness in the EAE model of MS. This will provide insight into what seems to be critical involvement of α9*-nAChR in cholinergic/nicotinic anti- inflammatory and immunosuppressive effects. Foundations will be laid for further mechanistic studies concerning α9*-nAChR and examining the therapeutic potential of α9*-nAChR subtype-selective ligands.

Public health relevance
PUBLIC HEALTH RELEVANCE: There are serious shortcomings in viable treatments for devastating inflammatory and autoimmune disorders, such as multiple sclerosis (MS). Recent, exciting discoveries implicate the natural chemical messenger, acetylcholine, in immune and inflammatory responses and reveal important interactions between the immune and nervous systems. Success in this project identifying α9*-nicotinic acetylcholine receptors in pro-inflammatory and immune responses would establish bases for development of novel therapies targeting those entities or downstream modulators in treatment of MS and perhaps other neurodegenerative disorders.